Molecular Tweezers: Potential Tools and Therapy for Amyotrophic Lateral Sclerosis

DESCRIPTION (provided by applicant): Amyotrophic lateral sclerosis (ALS) is an incurable, neurodegenerative disease characterized by progressive motor neuron loss, occurring in both sporadic and familial forms and leading to paralysis and ultimately death within 2-5 years after symptom onset. Currently, there are no effective treatments for ALS. Although the underlying pathogenic mechanisms of ALS remain unclear, protein aggregation is believed to be a major contributor to motor neuron death and subsequent disease progression. In this context, the most well- characterized system has been the assembly of Cu/Zn-superoxide dismutase 1 (SOD1) into neurotoxic oligomers and aggregates. The proposed study will investigate the effect of novel, recently-identified compounds called molecular tweezers (MTs) in cell culture and in a transgenic mouse model expressing the ALS-associated mutant, SOD1-G93A.The expected outcome is both enhanced understanding of the role of protein aggregation in ALS and establishing structure-activity relationships (SAR) for new MTs towards development of these compounds for disease-modifying therapy for ALS. MTs have been developed by the Bitan Laboratory as broad-spectrum, process-specific inhibitors of amyloidogenic proteins' self-assembly and toxicity. Initial in vitro data show that a lead MT called CLR01 inhibits both wild type and mutant SOD1 aggregation and dissociates pre-formed SOD1 fibrils. In collaboration with the Bitan group, the Wiedau-Pazos Laboratory found that CLR01 attenuates cell death in a neuronal cell line expressing the SOD1-G93A variant. These initial data suggest that MTs may be protective against motor neuron death in ALS via inhibition of aberrant aggregation of SOD1. Based on these data, I propose to examine novel MT derivatives in vitro and in cell culture to establish SAR of the key ionic groups and test the disease-modifying potential of the most promising derivative by evaluating its effect on life span, muscle strength, and neuropathology in a mouse model expressing SOD1-G93A.

Public health relevance
PUBLIC HEALTH RELEVANCE: Amyotrophic lateral sclerosis (ALS, Lou Gehrig's disease) is a debilitating, cureless neurodegenerative disease that causes premature death of central nervous system neurons responsible for skeletal muscle control and function. The quality of life of patients with advanced ALS is considered to be worse than death and the financial cost of ALS is exceedingly high due to the necessity of intense assisted-living care and medical equipment. Findings from the proposed study will provide insight into the cellular and molecular mechanisms underlying a familial form of ALS and explore a promising therapeutic intervention for ALS in the form of novel compounds potentially capable of slowing disease progression and improving patient quality of life.